Investigating the mycomembrane protein assembly pathway

PROJECT SUMMARY
The bacterial cell envelope functions as the cell’s primary defense against environmental threats, including
antibiotics. Rising levels of resistance to antimicrobial treatments demand the development of new therapeutics
that target this formidable barrier. Protein transport to the outer layers of the cell envelope is a high-priority
candidate for further therapeutic development as proteins that reside within the outer layers of the cell envelope
are critical in mediating interactions between the intra- and extracellular environment. The transport and
assembly of proteins that reside within the outer layers of diderm bacterial species is highly regulated due to
their importance for cell viability. Gram-positive microbial species in the Mycobacteriales order contain a protein-
rich outer layer called the mycomembrane (MM) that is functionally analogous to the Gram-negative outer
membrane. However, despite this diderm organization, the lipid composition and proteins that reside within the
MM are structurally distinct from Gram-negative bacteria. Additionally, Gram-negative outer membrane protein
transport pathways are not conserved and the mechanism through which mycolate outer membrane proteins
(MOMPs) are transported to the MM is an outstanding question in the field. By cross-referencing my preliminary
datasets from a FACS-based Tn-seq screen and immunoprecipitation for interaction partner with a surface-
exposed MOMP, I hypothesize that a family of redundant enzymes called mycoloyltransferases are MOMP
assembly factors. I will validate binding between mycoloyltransferases and MOMPs, characterize the binding
interfaces, and utilize a spheroplast-based transport assay to test the hypothesis that MOMPs are transported
across the cell envelope by mycoloyltransferases. Additionally, I have demonstrated through mass spectrometry
and immunoblotting that, in addition to the previously described lipidation of these proteins, MOMPs undergo an
additional post-translational modification that I propose is glycosylation. I will investigate the identity of the sugar
modification, determine the residues that are glycosylated, and identify the responsible glycosyltransferase.
Finally, I will investigate the dynamics of MOMPs within the MM using a surface exposed tag on a model MOMP
in relation to other layers of the cell envelope by fluorescence microscopy. The results of this work will elucidate
the essential process of MM biogenesis in the Mycobacteriales suborder, identifying novel targets for antibiotic
development against pathogenic members such as Mycobacterium tuberculosis. The Specific Aims of this K99
application are:
Aim 1: Investigate mycomembrane protein assembly factors
Aim 2: Characterize mycomembrane protein post-translational modifications
Aim 3: Analysis of in vivo global dynamics of proteins in the mycomembrane

Public health relevance
PROJECT NARRATIVE Bacteria in the Mycobacteriales order, which includes Mycobacterium tuberculosis and Corynebacterium diphtheriae, represent a major healthcare burden worldwide. The unique cell envelope of this group of bacteria contributes greatly to pathogenicity of members of this order as well as intrinsic resistance to environmental threats, including antibiotics. Here, I will investigate the biogenesis of the Mycobacteriales cell envelope in the model organism Corynebacterium glutamicum by characterizing the pathway that transports and assembles proteins into the unique outer membrane characteristic of bacteria in this order.